EFFECTS OF HEAT STERILIZATION FOR REPROCESSING POLYSULFONE DIALZYERS

This study proposes to give the opportunity to check the efficacy of heat sterilization reuse in terms of urea clearance. We will also be able to assess B2-microglobulin clearance, protein losses and the influence of this new type of dialyzer reprocessing on cytokines stimulation and macrophage function, as these have not been studies yet.